Pilot-Feasibility Core

ABSTRACT
The NASCARR Pilot-Feasibility Governance Core will serve to accelerate innovation in patient-centered sex
chromosome aneuploidy (SCA) research. The core is fundamentally designed to facilitate success of
translational research that has direct applicability to patient communities in domains with significant
stakeholder investment. To do so, the core will leverage substantial collective resources that will be assembled
through the overarching NASCARR RDCRC. This encompasses significant human resources in the form of a
comprehensive and collaborative network of SCA researchers, families, expert mentors; and also material and
structural resources, including access to financial sponsorship, recruitment channels and administrative
support. The ultimate goal of pilot-feasibility awards will be to generate innovative investigations into various
domains that are most likely to advance the SCA field toward clinical trial readiness, including (but not limited
to) biomarker discovery as associated with common phenotypes associated with morbidity/mortality in SCA
conditions; creation and/or validation of data collection tools and salient outcome measures specific to SCA,
validation of novel interventions and diagnostic tools in treatment of individuals with SCAs. It is expected that
the longitudinal outcomes of funded awards will be successful translation of pilot-feasibility into larger scale
clinical trials with the potential to directly impact clinical care of individuals with SCA.
To accomplish these goals, the NASCARR Pilot-Feasibility Governance Core is broadly centered on
three aims: Firstly, establishment of a robust pilot study grant mechanism – the core will develop infrastructure
using best practices in scientific review, to solicit, evaluate and fund innovative research in SCA. Processes will
include broad dissemination of a request for proposals to the SCA research and associated communities
inviting letters of intent and subsequently, full applications which will be reviewed for impact, innovation, rigor
and relevance, by content experts. Meritorious applications will be considered for funding by the NASCARR
Executive Council. Secondly, funded awardees will have access to a comprehensive network of established
SCA peers, and mentors, as well as resource support, to optimize success of selected grants. This includes
intellectual exchange with like-minded researchers, forums to review and incorporate up-to-date understanding
of SCA research frameworks, and facilitated access to a broad network of resources within the NASCARR
network and the RDCRN more broadly. Regular meetings and milestones will be established to ensure
greatest likelihood of success in transitioning from pilot awards to future clinical trials. Lastly, the core itself will
undergo regular and systematic review/evaluation to ensure the mission of the core is being met, while also
allowing intentional iterations on program structure as required year over year. This includes outcome
evaluation of funded awards and success of selected principal investigators, as well as review of progress
reports and presentations of completed awards to the NASCARR Executive Council, the DMCC and NIH, and
dissemination of findings to stakeholder communities.